Imaging

Project Summary-Imaging Core
The OVERALL aims of this Vision Research Core (VRC) are to provide:
· access to resources outside the scope of individual R01 awards
· access to technical expertise outside the scope a single laboratory
· staff training to remove barriers to efficient translational research and collaboration
· collaboration initiatives among VRC labs
The research areas supported by the VRC span the analysis of fundamental biology of normal tissues involved
in the visual system as well as a range of cutting-edge basic science initiatives involved in treatments of retinal
degenerations, developmental disorders, glaucoma and other disorders. We have implemented four resource
modules that continue the natural evolution of how this research group works together, serving 17 investigators
holding 22 NEI R01 awards.
The Imaging Module provides a range of imaging (TEM, confocal, metabolomic CMP, scanning optical) and
computing services (imaging, database, mathematics) based on strengths of core laboratories and the tradition
of excellence of the UU School of Computing, whose descendants founded Adobe Systems, Silicon Graphics,
Netscape and Pixar. Collaborations among these groups have transformed software tools for TEM and
confocal imaging.
Specifically, the Imaging Module provides:
• novel, powerful high-speed automated TEM for VRC investigators, regardless of experience, that
delivers top quality TEM imagery in a readily navigable format using the Viking web-application.
• metabolic mapping onto anatomy using Computational Molecular Phenotyping (CMP) resources.
• research grade confocal resources and management both in the JMEC proper and the JMEC vivarium;
expanded confocal resources are planned.
• high-speed optical scanning microscopy for high-throughput tissue / immunocytochemical analysis.
• extensive imaging, database and mathematics software holdings and training expertise
• large scale data storage for the VRC (up to 0.5 petabyte).